Mechanical deformation of the cell envelope as a form of surface-sensing in Pseudomonas aeruginosa

Project Summary/Abstract
Pseudomonas aeruginosa is an opportunistic pathogen that causes life-threatening infections in critically ill and
immunocompromised patients. The invasive success of P. aeruginosa is in part due to the ability of the pathogen
to form biofilms at surfaces. Biofilms protect P. aeruginosa from environmental stressors such as antimicrobials
and host immunity and present a major challenge in treating infection. This proposal aims to further
understanding of biofilm development to ultimately inform the design of new strategies that prevent biofilm
growth. To this end, innovative microfluidic devices are used with single cell fluorescence microscopy and
bacterial genetics to determine how P. aeruginosa senses and responds to mechanical deformation of the cell
envelope. Mechanical stress/strain in the cell envelope occurs when bacteria contact a surface due to adhesive
forces, but it is unknown how this cue is perceived and if it is transduced into biochemical signaling to trigger
adaption to a surface-bound lifestyle. The proposed research explores the overall hypothesis that mechanical
stress/strain in the cell envelope activates the Wsp system in P. aeruginosa which plays a major role in regulating
sessility and biofilm formation. The Wsp system is also required for infection in murine wound models and is a
common source of pathoadaptive mutations in clinical isolates, demonstrating its relevance to human health. In
Aim 1, innovative microfluidic devices pioneered in the cosponsors’ laboratories are used to immobilize single
bacterium and apply controlled mechanical stress/strain. Fluorescence microscopy is then used to establish a
quantitative relationship between Wsp signaling and mechanical stress and investigate the dynamics of Wsp
system components. While mechanosensing through cell envelope deformation has never been systematically
studied in P. aeruginosa, extracellular appendages are known to transduce other mechanical cues associated
with surface contact into biochemical signaling. Therefore, in Aim 2 disparate mechanosensing pathways are
compared under experimental conditions assumed to influence cell envelope deformation. We exploit a new,
dual-fluorescent reporter to simultaneously track expression of different signaling outputs for surface-sensing
systems in individual cells as a function of substrate and cell mechanics. Overall, the research strategy fulfils the
candidate’s training goals to 1) fabricate and design devices/materials with micro- and nanoscale features, 2)
understand and dissect bacteria sensing, 3) characterize changes in bacteria behavior and physiology using
quantitative microscopy. The candidate’s quantitative background in bioengineering combined with these new
skills in microbiology and microfluidics will differentiate them amongst other trainees and prepare them to pursue
innovative research on bacteria mechanosensing in their independent career. With multidisciplinary support from
their co-sponsors Prof. Engel (expert in P. aeruginosa genetics and mechanosensing) and Prof. Hernandez
(expert in microfluidics and biomechanics) and the resources available to them at UCSF, a world-renowned
biomedical research institute, the candidate is well-supported in their training goals.

Public health relevance
Project Narrative The opportunistic pathogen, Pseudomonas aeruginosa, undergoes a lifestyle transition upon surface contact that results in biofilm formation. Biofilms can contribute to the development of chronic and recurrent infections by protecting bacteria from environmental stress (i.e. antimicrobial, host immunity) and thus, new anti-biofilm therapies are of urgent need. To better understand how biofilms develop and inform the design of new therapies to prevent their growth, in this proposed work, we use innovative microfluidic tools and single cell microscopy, to determine how P. aeruginosa uses mechanical cues from the environment to detect surface contact and adapt to a surface-bound lifestyle.